Role of Class IIa HDACs HDAC4 and HDAC7 in Pathogenic Th17 Cell Development and Colitis

PROJECT SUMMARY
Th17 cells play important roles in adaptive immunity and autoimmune diseases. In normal physiological
conditions, Th17 cells produce IL-17A and IL-17F to protect the mucosa from bacterial and fungal infections.
Dysregulation of Th17 cells, however, is responsible for inflammatory bowel diseases, multiple sclerosis and
rheumatoid arthritis. Differentiation of Th17 cell lineage has been investigated intensively and has yielded
significant results. The cooperation of key transcriptional factors such as Irf4, Batf, Stat3 together with lineage-
specific regulator RorgT defines the transcriptional program and function of Th17 cells. These regulatory
networks are induced by IL-6 and TGF-b1, and further IL-23 signaling pathways promote the development of
pathogenic Th17 cells. To identify Th17-specific regulators, we recently conducted comprehensive ChIP-seq
and RNA-seq studies of Th17 cells and discovered Class IIa Hdacs Hdac4 and Hdac7 as candidates that are
transcriptionally regulated by Stat3 and BET proteins. We further found that Hdac4 and Hdac7 co-localize with
distinct transcription factors JunB and Bhlhe40 on cis-regulatory regions of genes, to activate Th17 pathogenic
genes (Il23r, Tgfb3, Il22, Csf2) and repress regulatory gene (Il10), respectively, during pathogenic Th17 cell
differentiation (IL-6+IL-23+IL-1b). However, we still have limited mechanistic understanding how Hdac4 and
Hdac7 function distinctly in pathogenic Th17 cell development. It is also unclear how Hdac4 and Hdac7
facilitate Th17 pathogenicity through the regulation of Th17 cell maintenance and/or plasticity in colitis. We
therefore aim to delineate the role of Hdac4 and Hdac7 in Th17 cell-mediated inflammation, and establish the
feasibility of pharmacological inhibition of Hdac4 and/or Hdac7 as a novel therapeutic strategy to treat Th17-
related colitis.

Public health relevance
PROJECT NARRATIVE This project aims to delineate the function roles of Hdac4 and Hdac7 in Th17 cell development and inflammatory bowel diseases. The outcome will empower the research community to better understand the fundamental molecular basis of Th17 cell transcriptional program and pathogenicity, and will have great implications in human health and autoimmune diseases, particularly inflammatory bowel diseases.